BIOMEDICAL (BASIC)

To establish and manage a Clinical Trials Operations Support Center. The overall purpose of the Center is to provide support for the management, tracking, and oversight of clinical trials sponsored by the Institute. The NIA is charged with ensuring the highest quality of each Institute-funded clinical research project and compliance with DHHSINIH/NIA regulations regarding human subject protections and safety monitoring. To carry out this responsibility, the NIA requires clinical trial-related scientific and management resources of the proposed Center.